Epigenetic Regulation of Mitochondrial Homeostasis and Energy Metabolism

PROJECT SUMMARY
Non-alcoholic fatty liver disease (NAFLD) contributes strongly to the development of insulin resistance, and the
two mutually regulate each other in type 2 diabetes. In the liver of NAFLD and insulin resistance, hundreds to
thousands of genes are either upregulated or downregulated. Epigenetic modifications such as histone
methylation and acetylation modulate homochromatin or heterochromatin states to enhance or suppress gene
expression in a context-dependent manner. However, significant knowledge gaps exist in mapping the epigenetic
landscape and identifying the major epigenetic factors regulating the development of NAFLD and insulin
resistance. In the current proposal, we take advantage of the newly developed CUT&TAG technology and create
an epigenetic landscape of histone modifications, including H3K4me1 (poised marker), H3K4me2, and H3K27ac
(active marker), and H3K9me2 (suppressive marker) in the liver of mouse and human NAFLD. A comprehensive
analysis of the histone modification landscape identifies RE1 Silencing Transcription Factor (REST) as an
epigenetic modulator that coordinates the activity of these histone markers. REST recruits histone deacetylases
(HDAC1&2), which deacetylate H3K27ac, and lysine-specific demethylase 1 (LSD1), which demethylates
H3K4me1 and H3K9me2, to regulate gene expression. Our preliminary data show that nuclear REST protein
levels are increased in the liver of mouse and human NAFLD. Insulin and glucose treatment of cultured
hepatocytes mimicking insulin resistance drives REST nuclear translocation. Knocking down REST using REST
antisense oligonucleotides (ASO) in the liver of adult obese mice (REST-LKD) alleviates fatty liver and improves
glucose and insulin tolerance. Hyperinsulinemic-euglycemic clamp studies show that REST knockdown in the
liver increases glucose uptake in adipose tissue and muscle, indicating crosstalk between the liver and adipose
tissue/muscle. These data show that hepatic REST is activated in insulin resistance, and the activated REST
promotes the development of NAFLD and insulin resistance, forming a vicious cycle. Our central hypothesis is
that REST is the key epigenetic factor orchestrating histone methylation and acetylation to regulate lipid and
glucose metabolism in NAFLD and insulin resistance. We propose three aims to investigate what causes REST
activation in NAFLD and insulin resistance, why the activated REST promotes NAFLD and insulin resistance,
and how the activated REST induces systemic insulin resistance. Aim 1: To determine the mechanisms for the
increased REST activity in the liver of NAFLD. Aim 2: To elucidate the mechanisms by which hepatic REST
regulates lipid and glucose metabolism. Aim 3: To investigate the mechanisms for improved systemic insulin
sensitivity in REST-LKD mice. Successful execution of the proposal will fill the knowledge gap by mapping the
epigenetic landscape and identifying REST as a key epigenetic factor that reprograms metabolic gene profiles
in NAFLD and insulin resistance.

Public health relevance
PROJECT NARRATIVE Hundreds to thousands of genes are altered in fatty liver and type 2 diabetes, yet how these genes are regulated is not fully understood. The current proposal identifies a novel epigenetic factor called REST that coordinates the expression of hundreds of genes involved in glucose and fat metabolism. The results will fill a knowledge gap in how epigenetic factors regulate the development of fatty liver disease and type 2 diabetes.